A novel force spectroscopy to study the ribosome power strokes and frameshifting

Dynamic and correct protein synthesis by the ribosome is essential to cell’s normal function, especially in muscle
and neuron cells. The intricate ribosome internal structure and elongation factors achieve fast and faithful peptide
elongation cycles at the expenses of GTP energy. However, mechanism and cellular level regulations of this
process in healthy and diseased cells are still not clear. For example, elongation errors due to amino acid
misincorporation and frameshifting are the fundamental causes for neuron degenerative diseases,
cardiovascular diseases, cancer, and viral infections. Regulation of the human ribosome translocase eEF2 via
phosphorylation is the only known normal functional modification, making the eEF2 kinase an extremely popular
drug target. However, how this modification affects the translocation is unclear. Similarly, mutations in eEF1, the
other elongation factor, causes congenital epilepsy and intellectual disability with unclear mechanism. In addition,
dynamic RNA modifications are connected with translation regulation and antibiotic resistance. We will tackle
these problems with super-resolution force spectroscopy (SURFS) that can directly measure the ribosome
toeprinting on the mRNA at both sides flanking the ribosome, and reveal the mechanical force’s role in this
movement. The outcome of this proposal is to prove the hypothesis of ribosome’s “inchworm-like” translocation
model that was proposed during the first supporting period. It will fill the current knowledge gap regarding
mechanical force’s role in translocation fidelity, reveal new therapeutic targets for related diseases, and generate
a new tool for biophysical research. Our research is unique because force in ribosome translation is only recently
confirmed and its mechanistic role is largely unknown. To our best knowledge, FIRMS and SURFS are the only
approaches that can probe both force and movement of ribosome. The aims are: 1) reveal the relationship
among power stroke, frameshifting, and kinetics using disease-causing mutations in elongation factors. EF-G
and EF-Tu’s mutations at the GTP binding pocket and EF-G’s domain IV loops interacting with tRNA are the
subjects. 2) investigate the roles of mRNA modifications, codon repeats, and antibiotics in translocation. Among
the 27 mRNA residues covered inside the ribosome, specific locations interact with the rRNAs to serve as the
brakes for reading frame maintenance. Modifications and antibiotic bindings at these locations are the focus in
this aim. In addition, how G-quadruplexes of repeating mRNA sequences induce frameshifting and alter the
kinetics will be revealed. 3) develop multiplex time-resolved SURFS. During the previous funding period, we
developed force-induced remnant magnetization spectroscopy (FIRMS) to resolve different reading frames and
determine the power strokes of EF-G and its modifications. Toward the end of the first funding period, SURFS
technique was developed that integrated acoustic radiation force with FIRMS to achieve five-fold better force
resolution. In this aim, SURFS will enable automatic multiplexed measurement with time-resolution. Therefore,
we will advance this technique with more efficient and precise measurements for force and translocation steps.

Public health relevance
Project Narrative We develop the multiplexed super-resolution force spectroscopy to investigate the mechanism of ribosome translocation during protein synthesis. We will measure the power strokes from elongation factors and their mutants during ribosome translocation on modified mRNA sequences and in the presence of antibiotics. Our research will provide new model about the ribosome translocation with sub-codon steps and provide potential drug targets for the related diseases.